Metabolic mechanisms underlying bronchopulmonary dysplasia-associated pulmonary hypertension

SUMMARY
Bronchopulmonary dysplasia (BPD) is a chronic lung disease in premature infants, caused by mechanical
ventilation and hyperoxia amongst other factors. Thirty percent of infants with BPD develop pulmonary
hypertension (PH), characterized by pulmonary vascular (PV) remodeling. There are no curative therapies for
this disease. My long-term goal is to develop novel targeted therapies to treat BPD associated PH (BPD-PH).
PV remodeling is characterized by increased pulmonary arterial media layer thickening. This results from
proliferation of vascular smooth muscle cells (SMCs), or transdifferentiation from endothelial cells (ECs) to SMCs
(i.e., endothelial-mesenchymal transition, EndoMT). We have shown that hyperoxia in newborn mice and
mechanical ventilation in preterm lambs cause PV remodeling resulting in PH, which is associated with increased
EndoMT. We preliminarily show that EndoMT is also observed in the lung of premature human infants requiring
mechanical ventilation. Blocking EndoMT prevents the progression of neonatal hyperoxia-induced PV
remodeling and PH in mice, suggesting that EndoMT plays a causative role in inducing PH. We observed no
increase in EdU incorporation into SMCs in hyperoxia-exposed mice, suggesting proliferation in these cells does
not contribute to PV remodeling in BPD-PH. We recently reported that neonatal hyperoxia causes a persistent
reduction of endothelial carnitine palmitoyltransferase 1a (Cpt1a), the rate-limiting enzyme of the carnitine
shuttle system responsible for transporting long-chain fatty acids into mitochondria for β-oxidation during fatty
acid oxidation. Our preliminary data show that lung Cpt1a gene expression is also reduced in mechanically
ventilated preterm lambs and premature human infants. Additionally, endothelial deletion of Cpt1a increases
EndoMT and PV remodeling in neonatal mice after exposure to hyperoxia. Furthermore, pharmacological
upregulation of Cpt1a attenuates EndoMT in vitro and prevents PV remodeling in neonatal mice in response to
hyperoxia. Whether neonatal hyperoxia and mechanical ventilation reduce endothelial Cpt1a, leading to PH is
yet to be determined. The central hypothesis is that neonatal hyperoxia and mechanical ventilation cause
EndoMT by downregulating endothelial Cpt1a levels, thereby resulting in PV remodeling and PH. We will test
this hypothesis in three Specific Aims. Aim 1 will determine the molecular mechanisms by which Cpt1a
downregulation contributes to EndoMT. In Aim 2, we will define the contribution of endothelial Cpt1a reduction
to BPD-PH and EndoMT. In Aim 3, we will evaluate endothelial Cpt1a as a therapeutic target for BPD-PH using
both lamb and mouse models. The combination of clinically relevant lamb and mouse models with our newly
generated EC-specific Cpt1a KO mice and the novel EC-targeted nanoparticle delivery system provides an
innovative approach to uncover the mechanisms by which Cpt1a downregulation mediates EndoMT and its
significant roles in BPD-PH. This contribution is significant because it is likely to result in new therapies
specifically targeting endothelial Cpt1a or EndoMT in neonates to treat BPD-PH.

Public health relevance
PROJECT NARRATIVE Supplemental oxygen and mechanical ventilation used in premature infants causes lung vascular remodeling and pulmonary hypertension. Our proposed studies will elucidate the metabolic mechanisms underlying endothelial-mesenchymal transition during the development of pulmonary hypertension using lamb and mouse models of bronchopulmonary dysplasia. This research will have significant translational potential for the development of novel pharmacological approaches targeting fatty acid metabolism or endothelial-mesenchymal transition to prevent pulmonary hypertension in patients with bronchopulmonary dysplasia.